Mechanisms of IgE-mediated regulation of monocyte antiviral response pathways

Project Abstract (from original application):
Virus infections are highly associated with the exacerbation of allergic diseases including allergic asthma,
atopic dermatitis, and allergic rhinitis. IgE-mediated allergic sensitization has been shown to impair antiviral
responses by innate immune cells such as monocytes- enhancing pro-inflammatory cytokine secretion,
disrupting phagocytosis, and inhibiting virus-induced maturation, IFN production, and altering CD4 T cell priming.
These findings suggest a role for IgE-mediated signals in modulating innate antiviral signaling pathways,
however little is known regarding the molecular mechanisms behind these observations. Given the significant
morbidity and economic impact of allergic diseases, a thorough understanding of IgE-mediated effects on
antiviral responses is critical for the discovery of new therapeutics for viral and allergic diseases. The goal of this
study is to determine how IgE-mediated allergic stimulation inhibits monocyte antiviral responses to regulate
cellular functions. Using primary human monocytes, we will utilize established molecular and biochemical
techniques in combination with advanced flow cytometry techniques (flow cytometry imaging and mass
cytometry) and transcriptomics to: (Aim 1) determine how IgE-mediated signaling components regulate early
antiviral recognition pathways, (Aim 2) determine the mechanisms by which IgE-induced IL-10 regulates
interferon receptor signaling, and (Aim 3) translate the in vitro findings by comparing monocyte antiviral
responses in individuals with high and low serum IgE. These studies will fill a large gap in our current knowledge
of how IgE-mediated processes modulate antiviral responses to promote virus-induced allergic exacerbations.
Dr. Regina K. Rowe, M.D. Ph.D. is currently an Assistant Professor of Pediatric Infectious Diseases at
the University of Rochester Medical Center. She received her Ph.D. from Washington University in St. Louis in
Molecular Microbiology and Microbial Pathogenesis where she investigated the interactions of hantaviruses with
the respiratory epithelium. She then received medical training at St. Louis University followed by Pediatric
Residency and Infectious Disease Fellowship training at UT Southwestern where her postdoctoral research
focused on the effects of allergic stimulation on monocyte-induced T cell priming. This career development award
will expand her expertise in systems immunology through training in cell signaling mechanisms, advanced flow
cytometry methods, and bioinformatics. As a pediatric physician-scientist, she will utilize her skills as an
infectious disease specialist trained in both human immunology and virology to establish a scientific platform to
answer a breadth of questions involving host-pathogen interactions in the context of human disease. Her
innovative approaches have the potential to identify new therapeutics to treat virus-induced allergic diseases,
and ultimately prevent disease development, exacerbation, and progression.

Public health relevance
Project Narrative (from original application) Virus infections are tightly linked to the development and exacerbation of allergic diseases, including asthma, allergic rhinitis, and atopic dermatitis. The immune response to virus infections are altered in allergic inflammation, however, little is known about the specific cellular pathways involved. The proposed research investigates how the allergic signals modulate critical antiviral cellular responses, providing potential targets for therapeutic intervention.